Cardiac regulation of heart failure and obesity

PROJECT SUMMARY/ABSTRACT
Heart failure impacts over 5 million Americans annually. Obesity increases risk factors associated with heart
failure. The gene MTCH2 has genetic variants that associate with both cardiomyopathy and obesity. The
human genetic data support that reduction of MTCH2 protein increases the risk for cardiomyopathy and
promotes a reduction in body mass. MTCH2 encodes an outer mitochondrial membrane protein important for
mitochondrial dynamics and metabolism, and MTCH2 protein was recently identified as an insertase for outer
mitochondrial membrane proteins. To study the role of cardiac Mtch2 in the heart, we created cardiomyocyte-
specific Mtch2 KO mice (cMtch2 KO). cMtch2 KO mice develop decreased systolic function in males earlier
than female mice. Male cMtch2 KO mice have reduced fat mass compared to controls prior to systolic
dysfunction. cMtch2 KO mice fail to hypertrophy their hearts in response to isoproterenol challenge, and
instead lose function and lose a large percentage of their body mass compared to controls. These data
support the idea that deletion of cardiac Mtch2 induces mitochondrial dysfunction and increases energetics to
maintain cardiac contraction at the cost of body fat. When challenged by a stressor, such as aging or
isoproterenol, the damaged mitochondria can no longer increase energetics required to maintain function. To
explore the mechanism by which reduced MTCH2 protein results in damaged mitochondria, we performed
mass spectrometry on mitochondria isolated from cMtch2 KO hearts revealing a significant decrease in
FUNDC2, a potential target of Mtch2’s insertase function. FUNDC2 is linked to mitochondrial dynamics,
apoptosis/autophagy, and activation of the transcription factor SREBP1. I hypothesize that reduction of
MTCH2 sensitizes the heart to diet-induced cardiomyopathy due to mis-insertion of FUNDC2. In Aim 1 of this
proposal, I will overexpress FUNDC2 in cMtch2 KO mice and determine if restoring FUNDC2 to the
mitochondria rescues both the development of cardiomyopathy and impaired body composition. In Aim 2, I will
measure how MTCH2 influences mitochondrial interactions with the sarcoplasmic reticulum and sarcomere. In
Aim 3, I will test if globally reducing Mtch2 leads to cardiomyopathy when sensitized by high fat diet. The data
gathered from these aims will elucidate the mechanism by which removal or reduction of MTCH2 from the
mitochondrial outer membrane induces mitochondrial dysfunction, sarcomere dysfunction, and ultimately,
impaired heart function.

Public health relevance
PROJECT NARRATIVE MTCH2 is a mitochondrial protein that can have genetic changes that associate with cardiac disease and obesity in humans. Removing Mtch2 from the heart causes the heart to malfunction and leads to loss of body weight in mice. This study will uncover how MTCH2 function is critical for the heart and obesity.